Reactive aldehydes and alcohol misuse in lung infections

Pneumonia is one of the leading causes of morbidity and mortality, particularly in older individuals. Importantly,
alcohol misuse has been associated with increased pneumonia for over 200 years. While the role of alcohol in
bacterial pneumonia susceptibility and severity remains to be fully understood, it is essential to define the at-
risk conditions and unique needs of those who misuse alcohol and to do so immediately in order to optimize
clinical care. Common in both active-duty and the veterans’ population, those with alcohol use disorders (AUD)
can be characterized by heavy cigarette smoking leading to pre-existing lung diseases such as chronic
obstructive pulmonary disease (COPD), a major co-morbidity for pneumonia. Our knowledge about how such
characteristics impact this pathogenesis is limited. However, results from our previous lung alcohol research
have already demonstrated that AUD are associated with cilia dysfunction. Our results also demonstrate that
AUD results in decreased surfactant anti-microbial action. Surfactant protein D has been documented to
specifically bind to and aggregate bacteria for optimal microbicidal action. We hypothesize that altered innate
lung defense at the level of mucociliary clearance and anti-microbial surfactants will negatively impact
susceptibility and pathogenesis of bacterial pneumonia, placing individuals with AUD particularly in harm’s
way. Our assembled team of investigators include a VA Research Career Scientist with 26 years’ experience in
the impact of alcohol on lung injury and repair, a VA pulmonologist whose expertise is on characterizing
primary human lung clinical samples, experienced alcohol liver injury researchers, and a junior investigator
who is already an expert in working with alcohol and bacterial infections. Our established expertise in mouse
models of alcohol injury combined with our existing biobank of human lung cells and tissues, we propose to
address our hypothesis by identifying any differences in S. pneumoniae infection responses due to alcohol
and/or cigarette smoking. We will specifically identify in these groups any changes in cilia beat controlling
clearance, surfactant protein D structure/function, and the role of reactive aldehydes generated by liver-derived
extracellular vesicles. Such studies will be performed for the first time in animal and cell models relevant to
AUD. Defining the modalities of risk will also empower clinicians to make informed preventive care decisions in
the context of alcohol misuse.

Public health relevance
The risks of severe disease or death from bacterial pneumonia are far worse in individuals with pre-existing lung disease, and it has been long established that alcohol use disorders (common in the Veterans’ population) lead to increased lung infections due to compromised innate lung defense. While reactive aldehydes are a source of this lung injury, their source and mechanism of action remains unknown. This study will define which at-risk conditions particularly impact those with AUD and their unique needs in order to empower clinical preventive care.